Project 2: Racial differences in host immune response and gastric carcinogenesis: Translating underlying biology to promote gastric cancer interception

ABSTRACT – Project 2
Gastric cancer is responsible for the third largest disparity in cancer incidence rates between Non-Hispanic
African Americans and whites. More importantly, African Americans are more than twice as likely to die from
gastric cancer than whites – the highest mortality disparity of any cancer. As a highly fatal cancer, gastric cancer
is the 6th leading cause of death from cancer among African American men. Most gastric cancers are caused by
Helicobacter pylori (H. pylori) infection, which is more common among African Americans than whites. Improved
understanding of the immune response to H. pylori has not translated into advances in screening, surveillance,
or cancer prevention. Indeed, Currently, the US does not have a strategy for gastric cancer screening and
surveillance. A cascade of events leads to gastric cancer, initiated by H. pylori infection, followed by changes
including chronic gastritis, intestinal metaplasia (IM), dysplasia, and cancer. Currently, little is known about how
racially mediated differences in response to H. pylori infection might result in increased gastric cancer risk. It is
known, for instance, that H. pylori virulence factors such as cytotoxic associated geneA, CagA, as well as more
virulent forms of vacuolating cytotoxin A, VacA, interfere with the host adaptive immune system to allow H. pylori
colonization in gastric mucosa. Moreover, certain CagA/VacA genotypes are associated with increased gastric
inflammation and epithelial degeneration. Our own preliminary data demonstrate that African Americans have
increased antibody responses to CagA and VacA, which correlate with increased risk of metaplasia and
dysplasia. However, the mechanisms through which race-associated genetic factors, such as IL-1β
polymorphism, relate to other virulence factors in the progression of precursor lesions and the pathogenesis
of gastric cancer are unknown. Our goal is to address these knowledge gaps and translate biologic findings
into new screening and surveillance strategies for clinical practice in order to address racial disparities and
improve survival related to gastric cancer. We hypothesize that H. pylori infection in African Americans is more
likely to result in an immune response that increases risk of intestinal metaplasia, dysplasia and evasion of
cytotoxic T cell response, explaining the underlying disparity in stomach cancer incidence and mortality. We will
create a retrospective cohort and test the hypothesis that racial differences in tissue-based immune response
along the gastric carcinogenesis cascade correlate with more advanced disease (Aim 1); and prospectively
compare racial differences in host response to H. pylori in fresh serum and tissue samples (Aim 2). This Project
will develop novel risk markers to be applied to a risk-stratification strategy that incorporates H. pylori virulence
factors and the immune-based signature found in high-risk African Americans, as a key step toward reducing
the disparity gap in gastric cancer screening, surveillance, and prevention.

Public health relevance
PROJECT NARRATIVE – Project 2 African Americans are more than twice as likely to die from gastric cancer than whites, and this mortality disparity is the highest among all cancers. Most gastric cancers are caused by Helicobacter pylori (H. pylori) infection, which is more common among African Americans than whites. This project addresses racial differences in host immune response and gastric carcinogenesis, and will lay the foundation for the creation of population- based precision prevention and/or interception strategies to reduce disparities in stomach cancer through targeted H. pylori eradication.